Role of DeltaNp63 alpha and TIP60 in SCC progression and chemoresistance

PROJECT SUMMARY / ABSTRACT
Cisplatin is frequently used to treat squamous cell carcinoma (SCC), frequently in combination with other drugs
or ionizing radiation (IR). Tumor recurrence due to therapeutic failure occurs in approximately 8% of patients
within 5 years of treatment, and the 5-year survival for individuals with recurrent disease remains around 55%
despite the recent introduction of targeted immunotherapies. The mechanisms regulating cisplatin resistance
remain poorly understood, representing a significant gap in knowledge with high clinical relevance. This proposal
will elucidate novel mechanisms of cisplatin resistance in SCC, thus opening new avenues for much needed
treatment strategies for chemoresistant HNSCC and enabling rapid advancements in the field.
∆Np63α is a proto-oncogene implicated in cisplatin resistance and overexpressed in SCC of the skin, head and
neck, cervix, and lung. We previously published that the TIP60 acetyltransferase directly acetylates and
stabilizes ∆Np63α to promote SCC cell proliferation. Our preliminary data indicate that (a) chemoresistance to
cisplatin correlates with high ∆Np63α and TIP60 levels in HNSCC tumors and skin SCC cell lines, (b) TIP60
inhibits the ubiquitination and degradation of ∆Np63α while increasing its acetylation, (c) silencing TIP60 or
inhibiting its HAT activity using TH1834 downregulates ∆Np63α, reduces its acetylation, increases cell apoptosis,
and sensitizes cells to cisplatin, and (d) we demonstrated an increased efficacy of cisplatin-IR treatment and the
IR-TH1834 combination demonstrating that TIP60 inhibition increases sensitivity to IR. We hypothesize that
TIP60 promotes cSCC and HNSCC proliferation and cisplatin resistance via enhanced stability of ∆Np63α and
function. To test this hypothesis, we will (Aim 1) determine how acetylation of ΔNp63α by TIP60 impacts the
ubiquitination and proteasomal degradation of ΔNp63α, (Aim 2) investigate how TIP60 mediated acetylation of
ΔNp63α alters transcriptional activity to impact apoptosis, the DDR and ultimately cisplatin resistance, and (Aim
3) elucidate the role of the TIP60/ΔNp63α axis in SCC progression and therapeutic response utilizing cell derived
xenograft models and efficacy studies in HNSCC PDX models to determine the effectiveness of a TIP60 inhibitor
as a potential therapeutic adjunct to standard of care chemoradiation (cisplatin and IR) treatment.
Together, the combined use of gain- and loss-of-function in vitro analyses, in vivo xenograft and PDX models of
cisplatin-resistant SCC will provide a statistically rigorous characterization of TIP60/∆Np63α signaling in cisplatin
resistance, apoptosis, and the DNA damage response in SCC; and will assess a potential novel therapy. This
will aid in the identification of additional potential therapeutic targets for the treatment of SCC and other epithelial
cancers, including nasopharyngeal and lung carcinomas and provide critical insights into the therapeutic
potential of acetyltransferase inhibitors.

Public health relevance
PROJECT NARRATIVE This study aims to delineate the specific mechanism(s) by which TIP60-mediated acetylation stabilizes ΔNp63α levels and modulates the DNA damage response, apoptosis, therapeutic resistance and squamous cell carcinoma (SCC) tumor progression using a combination of in vitro and in vivo models. This study is relevant to public health because it will provide (1) a mechanistic insight into the development of resistance to standard treatment modalities for SCC, (2) identify novel therapeutic targets in SCC with elevated TIP60 and ΔNp63α, and (3) assess the efficacy of TIP60 inhibition in sensitizing patient-derived (PDX) cisplatin-resistant head and neck SCC tumors to cisplatin and IR therapy. Thus, the proposed research is relevant to the NIH’s mission pertaining to the pursuit of fundamental knowledge to enhance health and reduce disability, and specifically to support of research into the mechanism of action of cancer therapeutic agents in both in vitro and in vivo model systems and the identification and validation of new druggable targets.